Usage of Novel Linked Databases to Improve the Perioperative Management of Patients With Alzheimers Disease and Related Dementias

PROJECT SUMMARY AND ABSTRACT
Many patients with Alzheimer’s Disease and Related Dementias (ADRD) undergo surgery. Indeed, patients
with ADRD patients account for 25% of patients undergoing hip fracture surgery and 10% of patients
undergoing high risk surgery. However, the extent to which these patients are at higher risk for adverse
postoperative outcomes remains unknown, with existing studies finding conflicting results. Moreover, while
many aspects of the management of these patients, such as the use of certain anesthetic agents and gases,
have been hypothesized to improve or worsen postoperative outcomes, the evidence base in support of these
hypotheses is weak. Our long-term goal is to advance the health of surgical patients with ADRD by developing
individualized models of risk assessment as well as evidence-based guidelines aimed at reducing this risk.
Towards this end, the overall objective of this study is to (a) identify the extent to which surgical patients with
ADRD are at increased risk for adverse postoperative outcomes and (b) estimate the association between
various perioperative interventions (e.g., use of anesthetic gases, choice of discharge location) and the
incidence of adverse postoperative outcomes. Specifically, this study will test the central hypothesis that
surgical patients with ADRD are at increased risk for adverse postoperative outcomes but that appropriate
perioperative interventions can reduce this risk. To assess this hypothesis, this study will use a novel linkage
between two datasets: healthcare claims data and the Multicenter Perioperative Outcomes Group (MPOG), a
large, multicenter registry of surgical cases using data extracted from electronic medical records. This linkage
will produce a unique dataset that unites the best aspects of both datasets: the ability to measure perioperative
care and the ability to follow patients over time to assess outcomes. We will accomplish the project goals
through three specific aims. First, using healthcare claims data, we will evaluate the extent to which patients
with ADRD are at increased risk for worse postoperative outcomes and identify the factors that mediate this
risk. Second, using the linked healthcare claims data-MPOG dataset, we will evaluate the association between
perioperative interventions (e.g., use of anesthetic gases, choice of discharge location) and the incidence of
adverse short-term outcomes. Finally, using the linked healthcare claims data-MPOG dataset, we will evaluate
the association between perioperative interventions and the incidence of adverse medium and long-term
surgical outcomes. The completion of this project will result in a comprehensive understanding of the risks
facing surgical patients with ADRD as well as the interventions that can reduce this risk. In addition, it will also
help identify targets for further study through randomized trials, and influence clinical guidelines and policies
aimed at improving population health outcomes among surgical patients with ADRD. Ultimately, the project is
in line with the agency’s priorities as its successful completion will improve shared decision-making between
clinicians and patients with ADRD and improve healthcare outcomes for surgical patients with ADRD.

Public health relevance
PROJECT NARRATIVE A large number of patients with Alzheimer’s Disease and Related Dementias (ADRD) undergo surgery, but the nature of their risk for postoperative complications as well as the decisions that can reduce this risk are unknown. This project will link electronic medical records data with administrative healthcare claims data to characterize the extent to which surgical patients with ADRD are at increased risk for postoperative complications and to identify clinical decisions (such as the use of anesthetic gases and choice of discharge location) that can reduce this risk. The results of this study will improve shared decision making and healthcare outcomes for surgical patient with ADRD by increasing what is known about the increased risks of surgery to these patients as well as the ways to manage these risks.